Goals of Care Discussions in Older Adults with Heart Failure and Their Caregivers

My career goal is to become an independent investigator whose work improves conversations between
clinicians and older patients with advanced heart failure (HF) and their caregivers. This application proposes a
five-year curriculum and research plan designed to facilitate my development to an independent investigator in
patient-oriented aging research. During the five years of the award, I will expand my research training and
experience through mentored research, formal coursework and self-directed learning activities and develop
independence through leadership and networking opportunities. The work proposed in this application involves
studying goals of care discussions (GOCD) in older adults with advanced HF. As one of the leading causes of
death, hospitalization, readmission and Medicare costs, HF is associated with poor health-related quality of life,
significant psychological distress and increased healthcare spending for patients and their caregivers.The
complex and changing trajectory of advanced HF along with the available life-sustaining therapies makes
decision-making more complex in older adults as compared to other serious illnesses. Recent data in
advanced cancer patients demonstrate that GOCD result in improved patient and caregiver outcomes. Unlike
cancer,
lifestyle
to
HF patients have highly variable prognoses, i nvasive potential treatments associated with major
changes, and unpredictable ymptom crises, which make it difficult to extrapolate findings from cancer
HF. This proposal aims to address this gap.
s
We hypothesize that improved GOCD will result in improved
patient outcomes (receipt of treatments aligned with preferences, better quality of life, less depression and
anxiety and decreased utilization) and caregiver outcomes (less depression, anxiety and caregiver burden, and
improved satisfaction) as compared to patients who do not have GOCD. The aims of these projects are: (SA1-
completed) to identify barriers and facilitators to GOCD in older adults with advanced HF and to identify patient
and caregiver health-related outcomes associated with GOCD; (SA2-completed) to develop and refine TIER-
PALLIATIVE CARE, an innovative palliative care delivery model to meet the unique needs of patients with
advanced HF or cancer; and (SA3) to conduct a pilot RCT of TIER-PALLIATIVE CARE to determine feasibility of
enrollment, efficacy to improve symptoms and quality of life. To achieve the first aim, I will analyze a
multicenter cohort of advanced HF patients and their caregivers to identify the factors that predict GOCD and
outcomes of these conversations. Next, I will interview patient/caregiver dyads to identify barriers and
facilitators of GOCDs. Using SA1 data, I developed and refined TIER-PALLIATIVE CARE (SA 2-completed).
Finally, with support from the supplement, I will conduct a pilot RCT of TIER-PALLIATIVE CARE (SA3) to
determine its feasibility and efficacy. These studies will generate data that will allow me to secure R01 funding
to test TIER-PALLIATIVE CARE in a multicenter RCT. The proposed research and career development plan are
initial steps toward improving the care of older adults with advanced HF and cancer and their caregivers.

Public health relevance
Public Health Relevance: Because heart failure is a disease of older adults, with more Medicare dollars spent on the diagnosis and treatment of heart failure than any other diagnosis, it is critical to gain an understanding of how goals of care discussions can be directed to improve care for this population and its caregivers. By understanding the determinants, barriers and facilitators of goals of care discussions in this population, we can design a tailored intervention to target effectively the needs of older adults with advanced heart failure and their caregivers; there has the potential implications for improving quality of care and minimizing cost of care for this population.